Admin-Core

Abstract
Administrative Core
The Administrative Core is essential for providing the capacity necessary to coordinate, supervise, track, and
manage all activities related to this ICEMR. The Administrative Core is designed to provide a supportive structure
sufficient to accomplish all Center’s goals. This ICEMR’s overall goal is to investigate the complex interactions
between the epidemiology of malaria and vector biology in Southeast Asia, with a focus on understanding the
dynamics of human and zoonotic malaria transmission and informing strategies for malaria elimination. This
activity involves many investigators based in Thailand, Malaysia, Japan, and the U.S. Thus, for our collective
efforts to achieve maximal efficiency and attain our stated research goals, our activities within and outside
malaria field sites must be well coordinated. Regular virtual and face-to-face meetings have been incorporated
into the plan. In particular, this core activity will oversee and manage all Center’s activities, monitor progress,
and ensure that project milestones are met effectively within the proposed timelines. The Administrative core will
arrange the travel for ICEMR Center’s key investigators for the mandatory annual SAG meetings and annual
ICEMR workshop meeting. The meetings provide opportunities for all partners to discuss and coordinate
activities for the project's success.